Enhance Cell Therapies for Peripheral Arterial Disease Using Human-Compatible Protease-Based Controls

Abstract: Over 8 million people in the US suffer from peripheral artery disease (PAD), which is
characterized by narrowing of the arteries in the arms or legs that lead to insufficient blood flow and
limb ischemia. A therapeutic strategy to treat PAD is to boost the formation of new vessels through a
process known as angiogenesis. We previously demonstrated that the delivery of human induced
pluripotent stem cell-derived endothelial cells (iPSC-ECs) improve blood perfusion and angiogenesis
in preclinical models of PAD. However, a major bottleneck is poor post-transplantation iPSC-EC
survival and the limited capability to reshape the local immune response. To overcome these
limitations, we propose to develop novel synthetic biology strategies that would enable the quantitative
and dynamic regulation of growth factors and cytokines produced from iPSC-ECs after transplantation.
Specifically, the strategies leverage a novel control knob we developed from a human protease and its
FDA-approved inhibitor, which would facilitate its eventual deployment in patients because of its
reduced immunogenic risk compared to existing control tools and the availability of off-the-shelf external
control. Specific Aim 1 is to engineer versions of a pro-survival growth factor (bFGF) and two
immunomodulatory cytokines (IL-10 and IL-19) that can be controlled by the protease. We will engineer
variants for protease-dependent activation and inactivation, achieved by fusing the target proteins to
“caging” domains that are removable by the protease and inserting protease cleavage sites into internal
loops, respectively. Specific Aim 2 is to test the pro-survival effect of the protease-controlled growth
factor on iPSC-ECs in vivo. We will achieve compact encoding of the entire system on a single vector
and validate its performance in vitro. We will then transplant the modified cells in a mouse model of
PAD. Output measures include bioluminescence to track cell survival and laser Doppler spectroscopy
to quantify vascular perfusion recovery. Specific Aim 3 is to examine the immunomodulatory effects of
the protease-controlled cytokines in vivo. After compact encoding and in vitro testing similar to Aim 2,
we will transplant the engineered cells in vivo and perform immunohistochemistry to quantify how they
affect the immune response at the transplantation site. These results will not only pave the way for
more effective stem cell therapies and immunomodulation of the ischemic limb environment for the
treatment of PAD, but also provide the first proof of principle for a control strategy that could be
generalized to other cell therapies.

Public health relevance
PROJECT NARRATIVE The transplantation of human induced pluripotent stem cell-derived endothelial cells (iPSC-ECs) is a promising cell therapy to treat peripheral arterial disease (PAD), but the survival of the cells after transplantation remains a major bottleneck. This proposal aims to improve the survival and clinical efficacy of iPSC-EC transplantation through a novel human-compatible protease engineered to serve as the control knob for secreting cytokines from transplanted iPSC-ECs. The therapeutic potential will be tested in animal models of PAD.